Targeting intramural von Willebrand factor (VWF) to improve vasomotor function, enhance brain parenchymal clearance, & delay development of cerebral amyloid angiopathy (CAA) in conditions of amyloid

SUMMARY.
The brain vasculature contributes to the vital clearance of Ab and other solutes from brain interstitial fluid (ISF). The
following proposal examines the pathological role of von Willebrand factor (VWF) within the wall of leptomeningeal
arteries and arterioles, with particular focus on its potential to impair cerebrovascular function and vascular-mediated
clearance in conditions of amyloidosis. VWF is expressed exclusively in endothelial cells and platelets and is widely
recognized for its role in hemostasis and thrombosis. The presence of extracellular VWF in blood vessels is normally
confined to the luminal endothelial surface and immediate sub-endothelial matrix. However, in certain pathological states,
VWF can be found within the vascular wall (i.e. intramural VWF) where it promotes smooth muscle proliferation and wall
thickening. Importantly, we and others have shown that VWF deletion profoundly prevents this vascular remodeling. Our
preliminary data now expand the role of intramural VWF to conditions of AD and CAA. We show the presence of VWF
within the smooth muscle region of cerebral arteries and arterioles from human AD and CAA patients and in
leptomeningeal arteries (LMA) from mouse models of amyloidosis. We further show that Ab peptides promote increased
VWF expression in human brain endothelial cells, supporting a contributory role for amyloidosis in VWF accumulation in
the vessel wall. Based on these findings, we propose the overall hypothesis that Ab contributes to increased basolateral
endothelial release of VWF, where it triggers smooth muscle proliferation and subsequent wall thickening with narrowing
of leptomeningeal arteries and cortical arterioles. We further propose that the consequences of intramural VWF include
cerebrovascular dysfunction, impaired brain clearance of Ab peptides, and the acceleration of cerebral artery angiopathy
(CAA) and related functional consequences. We propose studies to a) define the mechanisms by which intramural VWF
leads to pathological LMA remodeling and impaired Ab clearance and b) evaluate the novel strategy of reducing intramural
VWF to mitigate vascular-related pathology in amyloidosis. In Aim 1, we will test the hypothesis that Ab contributes to
increased basolateral endothelial release of VWF, where it triggers smooth muscle proliferation and subsequent wall
thickening with narrowing of LMAs and cortical arterioles. We will use a combination of human cell culture studies and in
vivo studies in TgAPP mouse models following selective VWF knockdown in brain endothelium. In Aim 2, we will test the
hypothesis that reduction of brain endothelial VWF will result in increased Ab clearance by improving transendothelial
and paravascular clearance mechanisms. We will evaluate selective knockdown of VWF in brain endothelium on different
components of ISF flow and Ab clearance in TgAPP mice. In Aim 3, we will test the hypothesis that knockdown of brain
endothelial VWF will prevent or stabilize vasomotor dysfunction and reduce vascular-driven pathology in conditions of
amyloidosis. For this proof-of-concept study, we will employ behavior testing, in vivo measures of cerebrovascular
function, and brain histological analyses to determine the beneficial effect of VWF knockdown in TgAPP mouse models. If
successful, these studies will establish the pathological role of VWF located within the vascular wall and thus provide the
initial experimental support for therapeutically targeting intramural VWF in conditions of amyloidosis.

Public health relevance
NARRATIVE. The proposed studies are based on the unexpected finding of a protein (von Willebrand factor, VWF) in the muscle layer of cerebral arteries of Alzheimer's disease patients and experimental mouse models. Our data suggest that VWF, when located in the muscle layer, contributes to pathological remodeling of the blood vessels and impairment of brain clearing of amyloid peptides. Using mouse models of elevated amyloid expression, we will 1) define the mechanisms by which VWF promotes pathology in the cerebrovasculature and 2) determine the therapeutic potential of reducing VWF in cerebral vessels.